U-RISE at Kennesaw State

Project Summary/Abstract.
Advancement of science is enhanced when researchers have diverse backgrounds, talents, and perspectives to
stimulate innovative and creative approaches that address healthcare challenges. The talent, experiences, and
participation of students from underrepresented groups have been demonstrated to be starkly low in science,
technology, and engineering and are worse at the highest levels of educational training (PhD). This project seeks
to establish the U-RISE at Kennesaw State training program to increase the number of underrepresented
students entering doctoral programs in the biomedical sciences. Four objectives have been set to achieve this
goal: (1) recruit five underrepresented biomedical science undergraduates per year for five years into the U-
RISE program; (2) retain at least four U-RISE trainees in biomedical degree programs at KSU for the duration of
their training; (3) provide U-RISE students a truly exceptional undergraduate research training, and; (4) facilitate
the successful transition of at least three U-RISE students into doctoral programs in the biomedical sciences.
Taking advantage of multiple recruitment avenues, a pool of high-achieving students from underrepresented
groups will be identified and nurtured. Successful program applicants will display an expressed interest in
pursuing a biomedical PhD or MD/PhD. Directed research and enrichment activities are planned for the two-year
appointment of each U-RISE trainee. Summer year one will feature training in foundational research skills,
responsible conduct, and methods to enhance reproducibility. In parallel, trainees will undergo three 2-week
research rotations before matching with their mentor. Throughout the junior and senior academic years, U-RISE
trainees will be required to conduct research with faculty mentors, while reinforcing core responsible conduct
and reproducibility tenets. Bi-monthly U-RISE seminars will build scientific identity, cohort cohesiveness, and
scientific communication. In spring semester year one, trainees will identify one or more labs at an R1 institution
to engage in summer research. After matching with their R1 lab, each trainee will spend U-RISE summer two
immersed in a 10-week R1 institute research experience. Fall semester year two will require an advanced team
research class, in addition to continuing projects with their KSU mentor. Fall bi-monthly seminars will prepare
trainees for doctoral program applications, while spring will feature doctoral interview preparation. Trainees will
receive peer and faculty mentoring throughout the two-year appointment. An advisory committee will oversee
program effectiveness. Using the above measurable objectives, survey instruments will be deployed by an
external evaluator to assess mentee training and mentor effectiveness. We will modify our program as needed,
based on survey outcomes. Results will be disseminated by our program website, conference proceedings, and
journal articles. If we are successful, at least fifteen U-RISE trainees will matriculate into biomedical PhD
programs over the five years of the project.

Public health relevance
Project Narrative. Biomedical research lacks a presence and voice from underrepresented scientists with doctoral training. This perpetuates a lack of diverse role models and talent in the biosciences. This U-RISE grant aims to tackle this problem head-on by recruiting, training, and mentoring up to 25 underrepresented students for entry into biomedical PhD programs.